Administrative Supplement to Modify Culturally-Relevant Recipes for Low-Income African American Women

Hypertension affects 122.4 million Americans, and African American (AA) women have significantly higher
hypertension estimates (58.4%) compared to White (42.6%), Asian (37.6%), and Hispanic (35.3%) women,
resulting in a disproportionate burden of cardiovascular disease (CVD). In the parent G08 study for this
administrative supplement, “DASH-ing to Heart Health: Supporting low-income African American women with
an interactive Meals that Heal resource book,” we proposed creating a useful and usable resource, Meals that
Heal, that increases awareness/knowledge of hypertension and improves ease of following a DASH diet by
providing culturally-relevant and low-cost DASH recipes that low-income African American women can utilize
when making heart-healthy food choices. DASH recipes in the parent award were compiled from existing peer-
reviewed publications and government, academic, and professional organizations. Although the DASH (Dietary
Approaches to Stop Hypertension) diet has been shown to significantly reduce the risk of hypertension and
other cardiovascular disease risk factors, we found that low-income AA women, such as those who live in
public housing and who may be at the highest risk for hypertension because of poor social determinants of
health, lack sufficient health information on how to feasibly follow this DASH diet. To preserve the project's
overall impact of reaching the full spectrum of AA populations, we propose new research aims in this
supplement to develop new culturally relevant low-cost DASH recipes. In addition, the parent award recruited
study participants from a public housing community in central Kentucky, limiting the generalizability (external
validity) of the Meals that Heal resource. In this supplement, we will increase our findings' generalizability by
recruiting study participants from additional public housing in a large Midwestern city with similar
sociodemographic characteristics. The aims of this supplemental request are to: (1) identify preferred culturally-
relevant recipes of low-income AA women by conducting qualitative interviews; (2) modify the culturally relevant
recipes to follow DASH guidelines and fit within a financially constrained food budget; and (3) evaluate the
effectiveness of Meals that Heal, with the modified culturally relevant low-cost DASH recipes, at increasing
DASH knowledge and the likelihood of using DASH recipes among low-income AA women. This supplemental
project is significant because the findings will increase the availability of culturally relevant and low-cost DASH
recipes for a health disparity population and increase the generalizability of Meals that Heal. This knowledge
can improve adherence to the DASH diet and the effectiveness of existing interventions, which is critical to
reducing hypertension disparities. Specifically, the results of this supplemental project will allow future studies
to identify evidence-based strategies to reduce blood pressure and hypertension risk.

Public health relevance
This supplemental project will increase the availability of culturally relevant and low-cost DASH (Dietary Approaches to Stop Hypertension) for low-income African American (AA) women and increase the generalizability of a targeted, useful, and usable interactive health information resource. Community-engaged approaches will be used to identify culturally preferred recipes and modify them into low-cost DASH recipes with AA women living in two low-income AA communities. Modified DASH recipes will be included in the health information resource and marketed to a broader audience through existing community-based partnerships and networks.